Clinical trials to prevent Alzheimer's Disease in Down Syndrome

PROJECT SUMMARY/ABSTRACT
The discovery that individuals with Trisomy 21, or Down syndrome (DS) have neuropathological
features identical to those with sporadic Alzheimer's disease (AD) played a critical role in the
identification of the amyloid precursor protein gene on chromosome 21 supporting the amyloid
cascade hypothesis. People with DS have a lifetime risk for dementia in excess of 75% and
comprise the world's largest population of genetically-determined AD. Just as studying DS
helped identify the role of amyloid precursor protein mutations in AD pathogenesis, it is also
likely to inform us of the potential benefit of manipulating the amyloid pathway on treatment
outcomes in AD. It is critically important to the DS population and to the AD therapeutics field to
conduct clinical trials, particularly those targeting amyloid accumulation, in individuals with DS.
With this application, we propose to utilize the existing depth and breadth of expertise of the
NIA-funded Alzheimer's Clinical Trial Consortium (ACTC) to conduct AD clinical trials in adults
with DS across performance sites with expertise in DS including the Alzheimer's Biomarker
Consortium for Down Syndrome (ABC-DS). As part of an NIH award received last year, we
established the ACTC-DS network which includes working groups comprised of leaders from
ACTC, ABC-DS and the European Horizon21 DS network to develop the collaborations,
infrastructure and plans required to conduct AD clinical trials in DS.
During the proposed R61 `Trial Readiness Phase' of the present project, in Aim 1, we will enroll
120 adults with DS (ages 35-55) across 15 sites into a trial ready cohort (TRC) to collect
outcome measures and biomarkers harmonized with those being collected in the ongoing ABC-
DS study (n = ~400). In Aim 2, we will determine the relationships between cognitive measures
and AD biomarkers to identify endpoints for clinical trials that best reflect disease progression.
During the R33 `Clinical Trial' phase, for Aim 3, we propose to implement a phase II
randomized, double-blind, placebo-controlled trial to evaluate the safety and tolerability of a
promising anti-amyloid therapeutic among individuals the TRC. In Aim 4, we will determine the
impact of this agent on biomarker evidence of disease modification.
Fundamentally, this project will serve to bring AD therapies to the DS population by leveraging
the infrastructure of ACTC and incorporating the experience and expertise of the ABC-DS and
Horizon21 networks. Beyond the proposed trial, this will establish the means and methods to
conduct future therapeutic trials in this population. The potential impact of this approach on
improving the lives of adults with DS as well as the general population cannot be overstated.

Public health relevance
NARRATIVE Therapies to treat AD in DS are urgently needed. This application seeks to utilize the existing expertise and experience of the Alzheimer's Clinical Trial Consortium (ACTC), Alzheimer's Biomarker Consortium for Down Syndrome (ABC-DS) and Horzion21 to establish a Trial Ready Cohort to conduct AD therapeutic trials in adults with DS in a thoughtful, ethical and scientifically-rigorous manner.